Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Overall Goal of the Environmental Health Disparities (EHD) Maternal and Infant Environmental Health
Riskscape (MIEHR) Research Center is to elucidate contributions of the biological, physical, social and built
environments of the environmental riskscape to environmental health disparities in pregnant women and their
infants. The MIEHR Research Center will conduct impactful research, engage communities and translate
research advances to reduce disproportionate health burdens among African-Americans and build community
resilience to improve maternal and infant health. As a new P50 EHD Center, the MIEHR Research Center will
have a unique identity as the focal point and catalyst for research and community engagement to reduce the
disproproportionate burden of environmental and place-based factors that underlie maternal and infant health
inequites in the Houston area. Center Director, Dr. Symanski and co-Director, Dr. Bullard, have experience
leading transdisciplinary research teams and a wealth of administrative experience in senior leadership positions
that will ensure the ability of this Core to effectively manage, integrate and evaluate MIEHR Center research,
engagement and training activities. Center Directors will be assisted in leadership of the Center by an Executive
Committee made up of Research Project Leads and Co-leads and Directors and Co-Directors of the Investigator
Development Core and Community Engagement and Dissemination Core, with additional guidance and input
from an External Advisory Committee and a Community Advisory Board. The Specific Aims of the
Administrative Core are:
Specific Aim 1: Develop and maintain an administrative structure that effectively manages the Center and
promotes attainment of MIEHR Center research, community engagement and career development
goals.
Specific Aim 2: Provide integration and build synergy across MIEHR Research Center Projects and Cores
that will drive improvements in the environmental riskscape of health disparity populations.
Specific Aim 3: Develop metrics and implement evaluative activities for MIEHR Center activities that will
facilitate successful completion of aims and programmatic objectives related to the Research
Projects, and the Investigator Development and Community Engagement and Dissemination Cores.
In summary, the Administrative Core will play a key role in ensuring the accomplishments of MIEHR Research
Center goals in research, career development and community engagement by integrating multidisciplinary teams
of community and academic experts from diverse backgrounds, and providing support for Center activities that
develop a diverse workforce of environmental health disparities researchers and community engagement that
fosters equitable community stakeholder interactions.